Smartphone-based diagnostic for HIV self-testing

SUMMARY ABSTRACT
The 90-90-90 Target endorsed by UNAIDS, proposes diagnosing 90% of people infected with HIV worldwide,
engaging 90% of them on effective antiretroviral treatment, and ensuring that 90% of those treated achieve
sustained viral load suppression by 2020. The United States is woefully unprepared to reach this target; only
30% of HIV infected individuals in the U.S. currently achieve viral load suppression. Clearly, a paradigm shift in
viral load testing will be required to accomplish this goal. This proposal aims to create a quantitative, handheld,
viral load self-test that can be used by patients themselves to support their management of this chronic
condition and that delivers relevant clinical insights to remote healthcare providers.
Building on our preliminary work, the objective of the R61 phase is to combine isothermal loop-
mediated nucleic acid amplification (LAMP) with a highly sensitive and label-free readout method called
particle diffusometry for quantification of HIV viral load in a hand held platform with minimal process steps.
Specific milestones include: 1) optimization of LAMP assays to ensure the lowest possible limit of detection, 2)
optimization of a microfluidic test chip for minimal sample prep, 3) algorithm development and testing to obtain
real-time viral detection. Assessment of usability and stakeholder needs with our partners at Moi University
(Moi) in Eldoret, Kenya, and Indiana University School of Medicine (IUSM) in Indianapolis, Indiana will ensure
that the handheld platform and HIV test will be readily adopted by stakeholders. At the conclusion of the R61
phase we will have a platform that is ready for implementation testing.
The objective of the R33 phase is to develop a proof-of-concept device that is validated in small
manufacturing runs and fully assessed against clinical performance metrics in plasma and whole blood. The
handheld platform and test chips will be evaluated for process control reproducibility and an initial pilot clinical
study will be performed with banked or prospectively collected samples from HIV patients at IUSM and Moy
University. The outcome of this R33 Phase will be a highly characterized, sensitive, quantitative handheld HIV
viral load detection platform that performs robustly with real clinical samples and is ready for scale up.
Completion of these objectives will position us for FDA pre-submission and regulatory approval, rapid
scale up, and implementation of a highly accurate HIV viral load self-test in the U.S. and East Africa. By
enabling patients to monitor their HIV viral load while remaining connected to healthcare provider support, we
will help to reduce barriers to treatment compliance and ultimately increase the number of patients with
sustained viral load suppression as called for by the UNAIDS 90-90-90 targets.

Public health relevance
PROJECT NARRATIVE While, viral load suppression is a critical to ensuring HIV infections do not progress to full blown AIDS, only 30% of the 1.1 million people living with HIV in the United States have actually achieved viral suppression. The goal of this proposal is to develop a handheld viral load self-test that can be used by HIV positive individuals to monitor their health between doctors' visits in order to engage and empower these patients. We hypothesize that development of a highly-sensitive HIV self-test that meets the needs of both patients and clinicians, will improve both patient quality of life and treatment compliance, thus improving clinical outcomes, reducing HIV complications, and ultimately resulting in healthcare cost savings.